Role of small RNAs in ischemic tissue repair

PROJECT SUMMARY
Cardiovascular disease (CVD) remains the leading cause of death, and there is a critical need to determine
underlying mechanisms and develop novel therapies for treatment. Small Cajal body-specific RNAs (scaRNAs)
are evolutionarily conserved non-coding RNAs that guide biochemical modification on specific nucleotides such
as pseudouridylation (Ψ) and 2′-O-ribose methylation (2′-OMe). These modifications are essential in the post-
transcriptional changes and functions of spliceosomal small nuclear RNAs (snRNA). Recent studies highlight a
crucial role of scaRNA in preserving spliceosome fidelity and cardiac development; however, the role of scaRNAs
in acute cardiac injury and its repair has not been established.
This
proposal aims to determine scaRNA’s role
in cardiovascular processes in a mouse myocardial infarction (MI) model that could develop new tools for treating
MI. Our central hypothesis is that overexpression of scaRNA18 in the post-MI heart promotes positive cardiac
remodeling by inducing therapeutic angiogenesis via 2′-OMe of U4 snRNA and regulating Wilms tumor1 (WT1)
expression, thereby conferring cardioprotection and improving cardiac function. Our preliminary data
demonstrates 1) decreased scaRNA18 expression in post-MI mouse hearts using unbiased small RNA
sequencing, 2) scaRNA18 expression exclusively downregulated in isolated cardiac endothelial cells (EC) in
post-MI mouse hearts, 3) scaRNA18 knockdown (KD) impairs tube formation and induces apoptosis in mouse
cardiac ECs without induced stress, 4) scaRNA18 overexpression enhances EC angiogenesis and inhibits
stress-induced EC apoptosis in vitro, 5) scaRNA18-overexpressing cardiac EC extracellular vesicles protect
iPSC-cardiomyocyte cell death via angiogenic proteins, 6) 2’-O-methylation levels were reduced in MI hearts
and in cardiac ECs from scaRNA18 KD mice, 7) mutant scaRNA18 lacking binding sites to guide 2′-OMe on U4
snRNA induces EC cell apoptosis without induced stress, 8) unbiased mass spectrometry results revealed that
scaRNA18 reduces WT1 expression levels in scaRNA18 KD cardiac ECs, 9) WT-1 KD in the presence of
scaRNA18 overexpression nullified scaRNA18 mediated EC survival effects, and 10) overexpression of
scaRNA18 by VE-cadherin-driven AAV9 reduces infarct size after ex vivo cardiac ischemia/reperfusion injury
and improves cardiac function post-MI mice (in vivo). The hypothesis that scaRNA18 is a critical component in
cardiac function and repair will be tested in the following three specific aims: in Aim 1, we will define the role of
scaRNA18 in cardiac EC function and cardiomyocyte survival; in Aim 2, we will determine the molecular
mechanisms by which scaRNA18 regulates cardiac EC function and cardiomyocyte survival, and in Aim 3 we
will use post-MI mice to demonstrate the critical role of scaRNA18 in myocardial injury repair. The proposed
studies could establish scaRNAs as novel therapeutic targets for MI.

Public health relevance
PROJECT NARRATIVE This proposal will investigate the therapeutic role of small Cajal body-specific RNAs in ischemic cardiac repair. Therefore, this proposal will be significantly relevant for progressing public health and enhancing the length and quality of life of millions of patients with cardiovascular diseases.